Mechanisms of accelerated calcification and structural degeneration of implantable biomaterials in pediatric cardiac surgery

SUMMARY
Despite legislation and federal initiatives, such as the Pediatric Device Consortia Grants Program, intended to
facilitate pediatric medical device development, innovation for pediatric cardiac patients continues to lag behind
the advances made for adult devices, making children requiring reconstructive heart surgery an underserved
population. All implantable biomaterials (glutaraldehyde bovine pericardium, xenograft valves and conduits,
cryopreserved allografts, autologous pericardium, and collagen bioscaffolds) as well as some artificial polymers
are subjected to structural degeneration driven by calcification (via passive calcium deposition and absorption of
calcium-binding proteins) and – as discovered by our group – by glyco-oxidation, which via permanent
incorporation of glycated protein and cross-links formation, alters the architecture and mechanical proprieties of
biomaterials.
This resubmitted application has two overarching goals: to understand the mechanisms of accelerate structural
degeneration of cardiac patches, valved conduits, and bioprosthetic heart valves in children and to test mitigation
strategies to extend the lifespan of these devices in vitro and in vivo by using juvenile animal models. Clinically,
the goal is to reduce the need for multiple cardiac re-operations in pediatric patients by mitigating the
mechanisms at the base of the accelerated failure. Preliminary results include a pediatric-specific bioregistry of
explanted cardiac devices, the development of precision medicine susceptibility assays using sera from pediatric
patients and adults, global proteomic analysis of absorbed proteins, and the utilization of two juvenile animal
models (rat subcutaneous implants of bovine pericardium and juvenile sheep undergoing surgical or
transcatheter aortic, mitral, or pulmonary valve replacement) to assess the role of enhanced protein absorption,
and calcification. We also developed methodologies to mitigate protein absorption. Based on these data will test
the hypothesis that mitigation of protein absorption of implantable biomaterial will reduce calcification and
structural degeneration of implantable biomaterial. Since our published and preliminary data, as well as
supporting literature, show that glycation and calcification precursors are overexpressed in children, we believe
that our mitigation strategies will be particularly efficient in pediatric patients. Overall, this project aligns with one
of the core missions of the NIH-NHLBI to improve the durability of multiple pediatric medical devices via a
precision medicine approach.

Public health relevance
NARRATIVE The goal of this application is to improve the durability of pediatric medical devices made of implantable biomaterials thus reducing the need for multiple cardiac re-operations in children. Our lab discovered that the permanent incorporation of circulating proteins via glycation can impair the structure of the biomaterials and favor the absorption of calcium-binding proteins. Since glycation and calcification precursors are overexpressed in children, we believe that our strategies to mitigate protein absorption will be particularly efficient in pediatric patients.